Discovering Heterogeneous Causal Pathophysiology of Alzheimer's Disease

Project summary
Alzheimer's disease (AD) represents a critical public health burden. Fortunately, recent disease-
modifying treatments for AD have demonstrated promising outcomes based on the successful
trials of Lecanemab and Donanemab. Nevertheless, how and when these Amyloid-beta-
lowering medications most affect cognition is not known. This is clear from the evidence
collected from both Lecanemab and Donanemab trials, where not all populations of participants
showed significant beneficial effects of anti-Amyloid-beta (Abeta) plaque treatment on cognition.
In this context, we aim to use existing datasets to understand AD pathophysiology progression
in heterogeneous subpopulations comprehensively. The established insight will reveal optimal
treatment windows for various populations, determining the precise timing and target groups for
whom reducing Abeta or tau levels is most likely to yield cognitive benefits.
In this proposal, we shall harness novel statistical theory and methodology to uncover the
heterogeneous causal pathophysiology of Alzheimer's disease with four specific aims in this
direction: (1) developing a new statistical method for heterogeneous causal discovery based on
the Amyloid cascade hypothesis, (2) developing a new statistical method for data-driven causal
discovery to uncover heterogeneous causal relationships among Abeta, tau accumulation, and
cognition in various subpopulations, (3) applying the proposed methods in Aim 1-2 across
diverse AD datasets and (4) developing software and dissemination research product.

Public health relevance
Project narrative Alzheimer's disease (AD) poses a significant public health challenge. Fortunately, recent advancements in disease-modifying treatments for AD, such as Lecanemab and Donanemab, have shown promising results through successful clinical trials. However, there remains uncertainty regarding the precise timing and mechanisms by which these Amyloid-beta-lowering medications impact cognitive function. In this context, we shall harness novel statistical theory and methodology to uncover the heterogeneous causal pathophysiology of Alzheimer's disease, and subsequentially apply these new methods in diverse AD longitudinal imaging datasets.